Characterization of PHF7 function in mediating cardiac reprogramming

Project Summary
The goal of this K08 application is to provide a rigorous 5-year scientific and career development training plan
that will facilitate the transition of Dr. Glynnis Garry from a post-doctoral fellow to a fully independent investigator
as a cardiovascular physician-scientist. Dr. Garry obtained her medical degree from Vanderbilt University during
which she pursued a rigorous and productive 1.5 year molecular biology training through a Sarnoff
Cardiovascular Research Fellowship at UT Southwestern in the laboratory of Eric Olson, Ph.D, one of the world’s
leading experts in muscle biology and cardiovascular regeneration. After completing a short-tracked Internal
Medicine residency at UT Southwestern through the Physician-Scientist Training Program, Dr. Garry joined the
laboratory of Dr. Olson as a post-doctoral fellow, where she directed her focus to investigating direct cardiac
reprogramming as a means of promoting heart regeneration following myocardial infarction. Reprogramming of
fibroblasts to cardiomyocytes has emerged as an attractive strategy to redirect the fibrotic response of the
injured, non-regenerative heart toward a functional myocardium. However, previously discovered cocktails have
been ineffective in reprogramming adult human fibroblasts, limiting the clinical application of this strategy. From
a large unbiased screen, Dr. Garry identified the histone reader PHF7 as the most potent activator of adult
reprogramming. Her preliminary work demonstrated the ability of PHF7 to markedly activate reprogramming in
adult human and mouse fibroblasts by increasing chromatin accessibility at cardiac super enhancers when
added to a five-factor reprogramming cocktail. She also discovered the ability of PHF7 to activate adult murine
reprogramming in the absence of canonical reprogramming factors. Further, she recently generated data
demonstrating the ability of PHF7 to improve cardiac function following myocardial infarction, which is an
unprecedented result that merits further characterization. In her proposed research, Dr. Garry under the
mentorship of Dr. Olson will aim to 1) define the role of PHF7 in adult human reprogramming, 2) define the ability
of PHF7 and PHF7 cocktails to improve cardiac function following myocardial infarction, and 3) delineate
mechanisms by which PHF7 induces reprogramming events and improvement in cardiac function in vivo. These
studies will potentially provide the basis for development of a novel therapeutic factor for the treatment of
ischemic heart disease and advance our understanding of mechanisms that drive reprogramming. Dr. Olson is
a pioneer in the field of cardiac reprogramming with a storied legacy of mentorship. He is fully committed to
mentoring the career of Dr. Garry, and together they have assembled an outstanding advisory committee to
ensure her success through scientific mentorship, grantsmanship, coursework, and career development
opportunities. Given her outstanding mentorship, productive research program, and full institutional support and
resources of UT Southwestern, Dr. Garry is well-positioned to launch a successful career as an independent
leading academic cardiovascular physician-scientist and submits a K08 award application to this end.

Public health relevance
Project Narrative Heart failure from ischemic heart disease is the leading cause of morbidity, mortality, and healthcare expenditure worldwide. The long-term goal and the clinical significance of this K08 grant is to provide the basis for the development of a novel therapeutic factor for the treatment of ischemic heart disease that promotes adult fibroblast to cardiomyocyte reprogramming following myocardial infarction. The results from these studies will deepen our understanding of mechanisms that drive reprogramming and serve as an important pre-clinical platform for the advancement of cardiac reprogramming therapies in patients suffering from heart failure and ischemic heart disease.